Dietary Impacts to Microbial Composition and Function in Eosinophilic Esophagitis

PROJECT SUMMARY/ABSTRACT
This K23 Patient-Oriented Mentored Award Proposal presents a structured 5-year research and career
development plan to prepare the candidate, Amiko Uchida, MD, to be an independent physician-scientist and
leader in the field of eosinophilic esophagitis (EoE). EoE is a chronic inflammatory esophageal disease
affecting nearly 1 in 1000 US individuals and is increasing in incidence. Despite the high frequency of EoE, its
pathophysiology is incompletely understood, resulting in limited treatment options and reliance on expensive
endoscopies for diagnosis and monitoring. One treatment is a food elimination diet. About half of EoE patients
respond to empiric removal of wheat and dairy (2FED) from the diet. While this has led to the idea that certain
foods trigger an inappropriate immune response against dietary antigen(s), there is a paucity of data to support
food-specific immune responses (e.g. antibodies) as the sole driver of EoE. Interestingly, eliminating more
foods does not always result in more remission, suggesting that EoE may be more complex and depend on
environmental factors like the microbiota. The microbiota is a crucial factor for many intestinal diseases and is
well-known to be affected by diet. The effects of 2FED on the intestinal microbiota composition and
metabolites, like short chain fatty acids (SCFAs), are unknown in EoE. Given our limited understanding of EoE
pathophysiology, there is a critical unmet need to understand how diet induced microbial changes impact EoE
to allow for novel therapies. Dr. Uchida is uniquely positioned to close this knowledge gap as she is an Adult
Gastroenterologist and co-Director of the Eosinophilic GI Disease Clinic at the University of Utah conducting
translational research on EoE. Dr. Uchida will build on her previous scientific and clinical training by
determining how 2FED impacts the microbiome and can be leveraged in EoE. Specifically, she will 1)
Characterize the fecal microbial metagenome, metatranscriptome, and metabolome associated with 2FED-
induced EoE remission, 2) Define serum IL-33 and metabolite changes associated with 2FED-induced EoE
remission, and 3) Delineate the contribution of SCFAs to eosinophil-intrinsic anti-inflammatory responses. Dr.
Uchida will investigate these aims under the guidance of her primary mentor June Round, PhD, who is a world-
renowned microbiome immunologist as well as her co-mentor Kathryn Peterson, MD MSCI, an acclaimed EoE
expert and clinician investigator. Both have long histories of training successful scientists and have established
a productive, integrated team with the candidate. Dr. Uchida will achieve her goals through the guidance of her
mentors, a scientific advisory committee, formal coursework, seminars, and hands-on training in advanced
laboratory techniques. The scientific environment of the University of Utah is particularly strong and offers
numerous scientific and career development resources. Successful completion of this project will inform the
development of new microbial-based therapeutics and non-invasive disease markers in EoE, and open
avenues of independent research for the candidate.

Public health relevance
PROJECT NARRATIVE Eosinophilic esophagitis (EoE) has become one of the most common esophageal disorders preventing normal swallowing in approximately 1 in 1000 patients in the US with only one FDA approved therapy and lacks non- invasive markers of disease. This knowledge gap is at least partially due to poor understanding of the interplay between the host and environmental factors like diet and the microbiome. This proposal aims to identify novel insights and therapies while changing current paradigms in the field of EoE and environmental factors.